Cellular and Molecular Mechanisms of Inhibitory Synapse Development

PROJECT SUMMARY
Synapses are the primary sites of cell-cell contact in the nervous system and are
required for the proper function of neural circuits. Signaling molecules expressed on the
neuronal cell surface during early development instruct synapse formation and specify the
identity of synapses as excitatory or inhibitory. Proper balance between excitation and inhibition
is essential for proper nervous system function. Perturbations to this process are implicated in a
variety of neurological and neurodevelopmental disorders including autism, epilepsy, and
schizophrenia. The proposed research will reveal key biological mechanisms of inhibitory
synapse formation and suggest pathways to target dysregulated excitatory-inhibitory balance in
various neurological disorders.
Despite a robust understanding of the molecular mechanisms of excitatory synapse
formation, relatively little is known about inhibitory synapse formation. Previous work indicates
that the cleaved transmembrane protein Semaphorin 4D (Sema4D), signaling via its receptor
PlexinB1, rapidly (~30 mins) promotes the formation of new inhibitory synapses in the adult
brain. In addition, Sema4D exclusively promotes inhibitory synapse formation while having no
effect on excitatory synapses, a property which thus far appears to be unique to Sema4D.
Further, previous work showed that treatment with Sema4D increases seizure resistance in
adult mice in vivo, suggesting that selectively increasing inhibitory synapse density may have
therapeutic applications.
This proposal aims to elucidate the biological mechanisms by which new inhibitory
synapses are formed in the central nervous system by utilizing the unique ability of Sema4D to
rapidly promote inhibitory synapse formation. Using a live imaging approach, the proposed
experiments seek to determine how elements of the pre-and postsynaptic specialization
coordinate in real time to rapidly assemble new synapses under the control of Sema4D. This
approach will also provide insights into poorly understood processes which have been observed
during synapse formation, such as the splitting of presynaptic and postsynaptic protein
assemblies. Finally, these experiments will reveal intracellular signaling pathways which
mediate Sema4D-dependent inhibitory synapse formation by manipulating signaling
downstream of the PlexinB1 receptor.

Public health relevance
Project Narrative Synapses are the primary sites of cell-cell contact in the nervous system which rely on protein signaling to determine when and where synapses will develop and to specify their identity as excitatory or inhibitory. Perturbations to this process are implicated in a variety of neurological and neurodevelopmental disorders including autism, epilepsy, and schizophrenia. We propose to utilize the demonstrated ability of Sema4D (signaling via the PlexinB1 receptor) to rapidly promote inhibitory synapse formation to study the mechanisms by which new inhibitory synapses are formed in the brain.